Detection and Characterization of Blood-borne Prions

No practical noninvasive antemortem test exists to detect cervid, human, or any, prion disease. Blood-
borne transmission of prions from asymptomatic human variant Creutzfeldt Jakob Disease (vCJD)-infected
humans has occurred(12,14-16). Chronic wasting disease (CWD) is an emergent rapidly spreading disease in
cervids(27,28,37-40) with uncertain zoonotic potential(3-8). An estimated one in 36 Americans hunt deer and/or
elk, resulting in an estimated 7,000-15,000 CWD-infected cervids consumed annually in the USA (increasing
20%/yr)(2). As hunting is a roughly $26 billion (per annum) industry(1), CWD represents an enormous potential
health and economic threat. The commonalities among vCJD and cervid CWD, including the presence of
hematogenous infectivity(34,47), are remarkable. Antemortem detection and surveillance of human, and
animal, prion disease has been hindered by the combination of low prion concentrations and abundant
assay inhibitors in blood and other accessible biological samples. We have developed simple, rapid,
specific and highly sensitive in vitro assays to detect blood-borne prions(9-11). In this competing renewal we will
quantitate the temporal distribution and specific blood cell phenotypes critical to prionemia in serially-collected
human and cervid blood samples.
The translational impact of the results of these studies will:
a) improve human blood transfusion safety,
b) provide a better means to assess and monitor developing prion therapeutics,
c) largely eliminate the risks of human consumption of cervid prions,
d) provide greater understanding of the prevalence and consequences of CWD to the cervid hunting and
agriculture industries, and
e) elucidate our understanding of prionemia in disease pathogenesis.
Thereby, this research will have immediate impacts in both human and animal health.

Public health relevance
No practical noninvasive antemortem test exists to detect cervid, human, or any, prion disease. We have developed simple, rapid, specific and highly sensitive in vitro assays to detect blood-borne prions (9-11). In this competing renewal we will quantitate the temporal distribution and specific blood cell phenotypes critical to prionemia in human and cervid blood samples.